Role for nuclear matrix proteins and DNA methylation for XCI maintenance in female lymphocytes

Females are predisposed for developing systemic lupus erythematosus (SLE), but the underlying mechanisms
remain obscure. Females have two X-chromosomes and equilibration of X-linked gene dosage to that of males
(XY) occurs by X-Chromosome Inactivation (XCI), initiated and maintained by Xist RNA. The X-chromosome is
enriched for immunity-related genes and X-linked genes are typically overexpressed in female-biased SLE,
suggesting that impaired XCI maintenance contributes to SLE. Unlike other somatic cells, we found that naïve B
cells lack enrichment of Xist RNA and heterochromatic marks, and that these modifications return to the inactive
X (Xi) upon in vitro stimulation, which we term `dynamic XCI maintenance'. Our published work demonstrates
that SLE patient naïve B cells exhibit abnormal expression of X-linked genes, suggesting a dysfunctional Xist-
independent mechanism involving DNA methylation for transcriptional silencing prior to autoantigen stimulation
could predispose to lupus. DNA methylation, associated with transcriptional repression, is reduced in SLE patient
B cells and is an important epigenetic modification for gene silencing on the Xi. XCI is also regulated by various
nuclear matrix proteins, such as hnRNPU and SAFB, which bind to Xist RNA and function to anchor Xist to the
Xi or the nuclear lamina in somatic cells. Our preliminary data support the novel concept that Xist RNA transcripts
are retained at the nuclear lamina by SAFB in naïve B cells, and that Xist RNA binds to hnRNPU upon B cell
activation, tethering Xist RNA to the Xi to regulate transcriptional repression. We have developed a novel Xist
deletion mouse model to determine how impaired XCI maintenance contributes to lupus disease, and our exciting
preliminary data show that increased dsDNA levels in type I interferon induced disease. Our central hypothesis
is that Xist-independent DNA methylation maintains transcriptional repression of the Xi and autosomes in naïve
B cells and that upon activation, alterations in nuclear matrix protein binding promotes dynamic XCI
maintenance, the dysfunction of which exacerbates Type I IFN-driven lupus disease. We will test our hypotheses
with the following aims: (1) Are reductions in Xist-independent DNA hypermethylation in naïve B cells associated
with aberrant gene expression in lupus? (2) How do interactions between SAFB, hnRNPU protein and Xist RNA
maintain XCI in B cells and does lupus disease impair cohesin eviction by hnRNPU-Xist RNA complexes? (3)
How does impaired XCI maintenance impact Type I IFN-driven lupus-like disease in female mice? IMPACT: Our
novel and innovative genetic and molecular approaches will yield unprecedented mechanistic insight into how
biological sex contributes to immune dysregulation of SLE disease, and will enable the identification of new
molecular pathways and targets of female-biased autoimmune disease that could be amenable for therapeutic
intervention.

Public health relevance
Females are biased to develop the autoimmune disease lupus, suggesting a genetic basis in the X-chromosome, which is enriched for immunity-related genes. We will investigate the molecular mechanisms specific to female B cells that regulate gene expression on the inactive X chromosome, and how alterations with these pathways impair B cell function and increase lupus disease severity in mice. Our findings will reveal genes predisposed to epigenetic alterations and aberrant expression for female-biased lupus disease.